Hemostasis and Thrombosis Program for Academic Trainees

DESCRIPTION (provided by applicant): Project Summary This renewal application requests continued support for the training program in Hemostasis, Thrombosis and Vascular Biology at the University of Vermont. The focal point of the program is the basic and clinical research training of M.D. and Ph.D. fellows (4 Post-doctorals, 4 Pre-doctorals and 2 Short-term). It is our intent to maintain this highly integrated and symbiotic research environment which extends training opportunities to predoctoral and postdoctoral students. Postdoctoral candidates with an M.D. degree typically enter the program following the first year of residency training, while Ph.D. candidates usually begin training immediately after fulfilling their degree requirements. M.D. /Ph.D. candidates begin after the 2nd medical school year. Short-term medical students participate in the research program during summer breaks with preferences given to students who wish to return for several summers. The heart of the training program is the research programs of the training faculty;all of w h o m has well established programs involving aspects of hemostasis, thrombosis, blood chemistry and vascular biology. The program faculty includes the Chairs of the Departments of Biochemistry, Anatomy/Neurobiology and Pathology, and other distinguished faculty members. There is a high degree of cooperative interchange among the laboratories of the faculty members. The training faculty has complementary research interests and a long history of close interaction on both research and educational enterprises. Primary training of the fellows in this program occurs within the research laboratory environment and is supplemented with formal educational programs within the University of Vermont including Seminars, conferences, journal clubs, and laboratory meetings. Both formal (didactic) and informal (seminar) ethics programs are in place. This program provides trainees with a strong background in basic research skills and allows trainees to join a vast network of collaborating investigators, including the current and former members of the participating laboratories. Trainees are therefore well prepared for future research endeavors in any field.

Public health relevance
Project Narrative This program has a major focus on the training of investigators who will deal with blood clotting and bleeding disorders. This research area encompasses major health problems including venous thrombosis, myocardial infarction and hemophilia which collectively have significant morbidity and mortality in the American population.